Human antibodies as broad alphavirus immunotherapeutics

SUMMARY
Chikungunya virus (CHIKV) is a mosquito-transmitted alphavirus that has caused large-scale epidemics on
multiple continents over the past decade. CHIKV infections can result in persistent and debilitating arthritis that
can last for years after infection. Related members of the alphavirus genus, including Mayaro virus (MAYV)
and Ross River virus, also are associated with severe musculoskeletal disease, whereas other more distant
family members, such as Western, Venezuelan, and Eastern Equine Encephalitis viruses cause central
nervous system disease and death. At present, there are no licensed therapeutics for alphaviruses. Moreover,
these viruses are significant global health threats due to the broad distribution of their mosquito vectors. Human
monoclonal antibodies (mAbs) are an attractive platform for virus immunotherapy because they are well
tolerated, highly specific, and can be engineered to have long half-life in vivo. We previously used single B cell
sorting to isolate a large panel of human mAbs from CHIKV patients during their convalescent phase or from
patients receiving a virus-like particle vaccine. These studies have led to: (i) the discovery of broadly
neutralizing mAbs that target the B domain of the E2 glycoprotein and protect mice from musculoskeletal
disease induced by CHIKV and MAYV; and (ii) the identification of pan-alphavirus mAbs that protect mice
against both arthritogenic and encephalitic alphaviruses by targeting a conserved epitope on E1. We will build
on these discoveries to develop new broadly inhibitory alphavirus antibody therapies. In Aim 1, we will engineer
Fc mutations into broadly protective antibodies to augment their in vitro and in vivo properties even further. In
Aim 2, we will perform viral escape studies to define mechanisms of neutralization and protection, and
determine if mAb cocktails are less susceptible to viral escape than single mAb therapies. In addition, we will
titrate pairwise ratios of mAbs in a cocktail, one neutralizing (E2-B-targeting) and one non-neutralizing yet
protective (E1-targeting) component, to explore synergistic relationships for in vitro and in vivo antiviral
activities. The most potent two-component mAb cocktail will be down-selected from studies in mice and then
tested for pharmacokinetic and efficacy profiles in non-human primate models of disease for both CHIKV and
MAYV (Aim 3). At the end of the funding period, we anticipate having proof-of-concept large animal data on a
broadly inhibitory alphavirus therapeutic mAb cocktail.

Public health relevance
NARRATIVE Alphaviruses are spread primarily by mosquitoes. Infection by alphaviruses can cause a range of signs and symptoms including fever, debilitating arthritis, and life-threatening encephalitis. There are many members of the alphavirus family but no approved therapies. This proposal explores new ideas for development of antibody therapies against alphaviruses as a possible broad-spectrum treatment.